Developing a Multivalent Subunit Particle Vaccine Against Tuberculosis

PROJECT SUMMARY
An effective vaccine is likely required to reduce the global burden of tuberculosis (TB). Development of one
has been difficult, in part due to the ability for Mycobacterium tuberculosis (Mtb) to reside for long periods
within host antigen (Ag) presenting cells (APCs), where it expresses a multitude of Ags, many of which have
been targeted for vaccine development. Recombinant Ags have been the focus of numerous vaccines,
however outcomes to clinical testing have been less than ideal. This R61/R33 proposal in response to program
announcement RFA-AI-21-007: “Innovation for Tuberculosis Vaccine Discovery” will leverage a next-
generation, vaccine adjuvant system that induces seamless particle-formation of recombinant Ags to assess a
multivalent Mtb vaccine. A new immunization paradigm will be advanced, based on combining (via simple
mixing) well-characterized soluble protein Mtb Ags with a vaccine adjuvant that induces spontaneous
nanoliposome-Ag particleization. Liposomes that contain small amounts of cobalt porphyrin-phospholipid
(CoPoP) bind to his-tagged Ags via spontaneous insertion of the his-tag into the bilayer. This approach gives
rise to rapid particleization that is stable in biological media. Recombinant Ags are simply admixed with CoPoP
liposomes at the time of vaccination (without further purification) to be fully converted for display on the surface
of ~100 nm particles. CoPoP recently completed phase I and entered phase II clinical testing as a key
component of a COVID-19 vaccine (NCT04783311). CoPoP also induces potent cellular responses using short
MHC-I restricted peptide immunogens at nanogram peptide dosing in mice; multiple orders of magnitude lower
dosing compared to Ag doses with conventional vaccine adjuvants. Preliminary data demonstrates that
multivalent particles decorated with the established Mtb Ags Ag85A, CFP10, ESAT-6, HSP-X, and Mpt64
induce protective cellular immune responses in mice. The underlying hypothesis is that multivalent, particle-
based Mtb Ags will induce a potently protective immune responses more effective than Bacillus Calmette–
Guérin (BCG) in multiple small animal models of TB infection. The R61 phase of the proposal will use mouse
models of TB infection to: (1) Develop well-characterized, multivalent Mtb Ag particles; (2) Assess how particle
parameters impact functional immunogenicity; and (3) Compare the efficacy of intranasal and intramuscular
particle administration. Ambitious and quantitative R61-R33 transitional milestones are proposed based on A)
generating well-characterized particles with storage stability with B) multivalent Ags providing superior
protection relative to the best single Ag particles with C) superiority to conventional BCG immunization in mice.
The R33 phase of the project will involve (4) assessing the vaccine in the guinea pig model, and (5) developing
and assessing the efficacy and toxicity of a lyophilized thermostable version of the vaccine.

Public health relevance
PROJECT NARRATIVE To design an effective design a multivalent TB vaccine, nanoparticles will be decorated with established recombinant antigens using a next-generation adjuvant system that induces seamless, spontaneous and biostable antigen surface display. Key parameters of particle formation will be examined and the vaccine will be benchmarked against Bacillus Calmette–Guérin (BCG) vaccination and tested in mouse and guinea pig animal models of TB infection.